NK cell mediated immune pressure in HIV-1 infection

DESCRIPTION (provided by applicant): Natural killer (NK) cells are cytotoxic effector cells of the innate immune system that have been shown to play a central role in the control of viral infections, and increasing evidence suggests that NK cells also contribute to the control of HIV-1 infection. The presence of particular NK cell receptors, killer immunoglobuline-like receptors (KIRs) encoded in conjunction with their HLA class I ligands is associated with slower HIV-1 disease progression and better control of viremia, and NK cells expressing these protective KIRs have been shown to strongly inhibit HIV-1 replication in vitro. The goals of this proposal are to determine whether NK cells can mediate antiviral activity in HIV-1-infected individuals in vivo, and to identify the precise receptor/ligand interactions involved in the NK cell recognition of infected cells. The PI proposes to test the hypothesis that NK cells can impose significant immune pressure on HIV-1 in vivo, forcing the virus to evade NK cell mediated immune pressure by selecting for NK cell escape variants. If successful, these studies will establish NK cells as a new important effector cell population that, in concert with virus-specific CD8+ T cells and B cells, contributes to the control of HIV-1 replication in infected individuals and to HIV-1 diversity. These findings will have an important impact on the HIV-1 field by providing the rational to harness this arm of the antiviral immune response for HIV-1 vaccine design, in particular given the recent description in mice that NK cells can mediate immunological memory to viral infections.

Public health relevance
Increasing evidence suggests that NK cells contribute to the control of HIV-1 infection. The goals of this proposal are to determine whether NK cells can mediate antiviral activity in HIV-1-infected individuals in vivo, and to identify the precise receptor/ligand interactions involved in the NK cell recognition of infected cells. The results from these studies will have an important impact on the HIV-1 field by providing the rational to harness this arm of the antiviral immune response for HIV-1 vaccine design.